Core A: Administrative Core

CORE A ABSTRACT
Core Lead: Ronald Hoffman, MD
The Administrative Core provides the infrastructure for and coordinates all activities of the Myeloproliferative
Neoplasm-Research Consortium (MPN-RC). The goal of the Core is to actively and dynamically maintain a
collaborative translational research network that supports and synergizes the laboratory and clinical studies led
by MPN-RC investigators. Key functions include organizational management and communication, resource
allocation and financial management (personnel, funds, equipment, and supplies), organization of all internal
and external advisory boards and committees, scientific and clinical trials oversight to ensure regulatory
compliance and procedural implementation, and external liaison to appropriate governmental agencies. The
specific aims of the Administrative Core are: (1) Coordinate the activities of all MPN-RC Projects and Cores and
monitor their progress and effective use of shared resource Cores; (2) Schedule and provide optimal staff
support for all MPN-RC committees and boards; (3) Assure that research involving the use of human subjects
and vertebrate animals is pursued in compliance with NIH regulations; (4) Establish all contracts with
participating organizations and administer and oversee all budgets and the disperal of funds; (5) Liaison to the
NCI and MPN patient advocacy groups for all matters pertaining to the MPN-RC; (6) Develop and negotiate
budgets and contracts with pharmaceutical companies to gain access to drugs for clinical trials to be pursued by
Project 4; (7) Develop criteria for institutional membership in the MPN-RC and assist in membership applications
and site initiation visits. As well as, monitor performance of all members to assure that they are optimally
functioning in a fashion that merits their continued participation; (8) Prepare annual progress reports to be
submitted to the NCI. Orchestrate the resubmission of this competitive renewal application to the NCI; (9)
Maintain and update the MPN-RC website; (10) Raise supplementary funds to assist in funding the MPN-RC
activities; (11) Establish and maintain educational activities in MPN research and treatment, and maintain
communications with the MPN patient community with the updates on the activities of the MPN-RC.

Public health relevance
CORE A Narrative Core Lead: Ronald Hoffman, MD The Administrative Core of this Program Project is designed to provide scientific leadership, effective communication and an administrative support structure, and to ensure the collaborative translational research network that supports and synergizes the laboratory and clinical studies led by MPN-RC investigators is maintained. The essential services provided by the Core include, but are not limited to: administrative support for all of the investigators in each project and core; fiscal management and oversight for all components of the Program Project; and organization and communication of all Program Project meetings and activities. Additionally, the Core will work with various foundation and MPN patient community groups to disseminate updates on MPN research and treatment.